The Simian Collective Conference

Project Summary.
This application is a request for funds to support a conference entitled the ‘Simian Collective’ that highlights
nonhuman primate neuroscience research in the United States, its unique role as a translational model of human
neuropsychiatric disorders, and how it seeks to build crucial community effort to address the key challenges
facing the field in the 21st Century. The conference is strategically organized to stress that maximizing the impact
of primate neuroscience research in the modern era necessitates complementary goals of Science, Ethics,
Education and Advocacy. Owing to the shared functional organization of the primate brain, our simian cousins
are uniquely powerful models to elucidate many facets of human brain function in both health and disease. This
cutting-edge research must continue to grow and receive renewed investments to prosper. The meeting will also
emphasize that the phylogenetic advantages of using a primate model, which shares many unique neural and
cognitive characteristics with humans, for investigative research must also be balanced by the crucial
neuroethical considerations that inevitably emerge because of these similarities. Furthermore, the Simian
Collective will also emphasize the responsibility of the field to educate our scientific colleagues and the general
population about the unique importance of primate research and to advocate for its significance. The program
of the meeting has been designed to emphasize the complementary relationship between these core tenets, and
to build a community initiative to build and promote primate neuroscience research in the coming years.

Public health relevance
Project Narrative. The principal goal of the Simian Collective is to highlight the significance of primates in neuroscience research, including their unique significance as translational models of human neuropsychiatric diseases and disorders. The meeting is organized to emphasize that realizing the maximal impact of primate models in the 21st Century necessitates complementing cutting- edge research with neuroethical considerations, as well as educating the broader scientific and general communities about the importance of primate neuroscience research. This meeting will provide an important forum to build the community involvement needed to take these critical steps in the next chapter of the field.